Understanding hematopoietic stem and progenitor cell diversity during ontogeny

PROJECT SUMMARY
The goal of this project is to understand hematopoietic stem and progenitor cell diversity
during ontogeny. Hematopoietic stem cells (HSCs) are self-renewing, multipotent stem cells that
maintain the entire blood system through a process called hematopoiesis. During embryogenesis,
HSCs emerge simultaneously with HSC-independent Progenitor Cells (HPCs) that have limited
self-renewal capacity and a lesser differentiation potential than HSCs. Interestingly, HPCs have
been shown to be necessary and sufficient to sustain embryonic hematopoiesis and are critical
to hematopoietic health. Therefore, understanding how these progenitor populations are
regulated differently from HSCs is critical to advancing protocols for generating HPCs and HSCs
in vitro and for understanding aberrant hematopoiesis. Developmental hematopoiesis is layered,
where overlapping waves produce blood cells in the embryo. HSCs and HPCs emerge from the
hemogenic endothelium (HE) via an evolutionarily conserved process termed the endothelial-to-
hematopoietic transition (EHT). Evidence in the field suggests that these HSCs and HPCs are
emerging from distinct HE cells, indicating that HSC or HPC fates are determined early in
hematopoietic development. One major difficulty in studying HSCs and HPCs is that they emerge
in a spatially and temporally overlapping manner and express many of the same markers. Our
lab developed a novel lineage tracing assay that temporarily distinguishes developmental HSCs
and HPCs in vivo by assessing their distinct differentiation properties. Additionally, we performed
scRNA-seq on newly emerging hematopoietic stem and progenitor cells (HSPCs) and defined
distinct gene signatures for HSPC populations. Based on the collective findings, we hypothesize
that the distinct differentiation by HSCs and HPCs is set up during their embryonic
formation and is regulated by discrete factors. In Aim 1, we seek to understand the ontogeny
and differentiation potential of a poorly defined HPC subset, Lymphoid Progenitors (LyPs), and in
Aim 2, we seek to determine the impact of transcription factor Tcf15 in regulating HSPC
specification and functionality. Knowledge gained from this proposal will identify distinct
characteristics and molecular mechanisms that differentiate HSCs from HPC with implications for
human hematopoietic and immune disorders and their treatments.

Public health relevance
PROJECT NARRATIVE Hematopoietic Stem Cells (HSCs) are responsible for sustaining lifelong hematopoiesis and are clinically valuable in hematopoietic replacement therapies for treating a variety of hematological diseases and cancers. In embryonic development, HSCs form concurrently with HSC- independent Progenitor Cells (HPCs) that have a more limited capacity to generate mature blood cell lineages yet are invaluable in establishing early hematopoiesis. Our study will identify distinct characteristics and molecular mechanisms that differentiate HSCs from HPC with implications for human hematopoietic and immune disorders and their treatments.